The role of cortical D1R-expressing neurons in taste-based sensorimotor transformations

PROJECT SUMMARY
To survive, animals must use gustatory sensory stimuli to inform and guide reward-oriented actions like
licking and chewing. Previous work examining this process, known as sensorimotor integration, has established
the anterior lateral motor cortex (ALM) as a model brain region to study sensorimotor processing related to
licking. Neural activity within this region reflects sensory information and motor planning of licking, implicating
ALM in mediating sensory-based lick decisions. However, it remains unknown if ALM is involved in taste-guided
sensorimotor integration – despite licking and taste being invariably connected – and whether this process in-
volves dopaminergic circuits. Blockade of D1R signaling within ALM has been found to affect both sensory-
evoked responses and motor planning of stimuli-guided licking, suggesting a potential role for ALM neurons
expressing D1Rs (D1R+ neurons) in lick-related sensorimotor transformations. However, the contributions of
D1R+ neurons in taste-guided sensorimotor integration remains unstudied. This proposal will test the central
hypothesis that D1R+ neurons are required during gustatory sensorimotor transformation and exhibit patterns of
activity representing gustatory processing and preparation of lick choice. The proposed experiments will rely on
a recently established 4-taste, 2-alternative choice (2-AC) task in which mice must sample one out of four
tastants (i.e., two sweets: sucrose, maltose and two bitters: quinine and sucrose octaacetate) from a central
spout and associate pairs with opposite perceptual qualities with specific actions (i.e., sucrose or quinine → lick
left vs maltose and sucrose octaacetate → lick right) after a delay period. To study the role of D1R+ neurons
during this behavior, I will utilize a combination of cutting-edge techniques that include cell-type specific optoge-
netic manipulation and 2-photon calcium imaging. To my knowledge, these will be some of the first experiments
examining the link between gustatory sensorimotor processing and neurons expressing D1Rs.

Public health relevance
PROJECT NARRATIVE The mechanisms used by the brain to form decisions related to ingestion remain unknown. This proposal will use optogenetic manipulations and optical imaging in behaving mice to investigate how a population of cortical neurons responsive to the major neuromodulator, dopamine, contributes to taste-guided decision-making. The potential findings of this proposal will provide novel insight on the nature of decision formation that is applicable to eating disorders and neuropsychiatric disorders caused by dopamine dysfunction.